Dana-Farber/Harvard Cancer Center

Overall Project Summary / Abstract Now in its 17th year of operation, Dana-Farber/Harvard Cancer Center (DF/HCC) was the first consortium model, NCI-designated Comprehensive Cancer Center in the country. The consortium is comprised of 1,100 members from five principal Harvard-affiliated hospitals and two Harvard health science schools: Beth Israel Deaconess Medical Center (BIDMC), Boston Children's Hospital (BCH, Brigham and Women's Hospital (BWH), Dana-Farber Cancer Institute (DFCI), Harvard Medical School (HMS), Harvard T. H. Chan School of Public Health (HSPH), and Massachusetts General Hospital (MGH). The progress presented in this proposal has required DF/HCC leadership, its combined resources, and, most importantly, its consortium structure. The overarching scientific vision is to unite the members. The research of the Center is carried out in Research Programs that cross both scientific and institutional boundaries. In addition, the Center supports Shared Resources dedicated to enhancing scientific efficiency available to all Center members. The unified clinical research infrastructure has made it easier for members to conduct clinical trials across the Center. Indirect indications of scientific progress are the substantial growth in the Center's grant portfolio, from $233 million in 1999 to $406 million in 2004, to $623 million in 2009, to $683M and the award of multiple translational grants that transcend organizational boundaries (e.g., SPOREs, SCORs, P01s, U01s, and SU2Cs). There is also an array of hypothesis-driven, Early Phase (pilot, I, I-II), and proof-of-concept trials, made possible through the development and execution of the Center, that are conducted daily across the consortium.

Public health relevance
Overall Project Narrative The primary goal of the Center is to promote collaborative interactions that will lead to new approaches to cancer prevention, diagnosis, and treatment.